Diversity Supplement

Parent R01 Project Summary / Abstract
Provided on first page of Research Strategy as required per the FOA.

Public health relevance
Project Narrative This diversity supplement to 5 R01 CA266879-02 will provide funding for UI post-baccalaureate student Daniel Robles to conduct research as part of the parent grant, pursuing a goal of being admitted to medical school, becoming an independent physician scientist in radiation oncology and entering the cancer workforce.